Cancer Research Career Enhancement and Related Activities (CRCERA)

ABSTRACT – CRCERA
The Cancer Center is part of the Sanford Burnham Prebys Medical Discovery Institute, a nonprofit accredited
degree-granting research institution in La Jolla, CA. We are one of seven NCI-designated basic research cancer
centers. Our researchers conduct paradigm-shifting, collaborative, multidisciplinary basic research into the
causes, prevention, and treatment of cancer, with the goal of developing new therapies that alleviate human
suffering and disease. We are dedicated to the education, training, and mentoring of our researchers, and are
committed to providing experience and education in cancer research to minority and disadvantaged high school
and undergraduate students from the San Diego area. We also provide a full spectrum of graduate student and
postdoctoral educational and training opportunities in preparation for employment in academia, biotech/pharma,
and other related professions. Mentoring and career enhancement support and opportunities are provided to
both tenured and non-tenured cancer center faculty. We also provide a platform for cancer patients, survivors,
and advocates to provide input and feedback through a Community Advisory Board, and we conduct public
outreach through a program of open houses and other community educational events.